Core C - Mutagenesis, Screening and Cryopreservation

PROJECT SUMMARY/ABSTRACT
The personnel in Core C have years of experience in breeding, housing and conducting experimentation with
NOD mice, which develop spontaneous T1D under specific pathogen-free conditions. A very specific
requirement for NOD mice is impeccable hygiene of the colony since minimal variations may affect T1D incidence
in both female and male mice. A strict program of sibling inbreeding, storage of embryos from highly inbred stock,
and periodic recovery of embryos from this stock is also necessary to prevent genetic drift of the type that led to
the establishment of the NOD/NckH and NOD/NckL sublines. Core C will generate 350 pedigrees of NOD/NckH
G3 mice modified by N-ethyl-N nitrosourea (ENU)-induced mutations. Pedigrees generated during the program
will exhibit an average of approximately 60 germline coding/splicing mutations and include >80 G3 female mice.
Each ENU-treated G0 male will be bred to NOD/NckH females to obtain 10-20 G1 male founders. These will be
retro-orbitally bled to recover high quality DNA for Illumina sequencing, and tail cuttings will be used to isolate
DNA from all G2 and G3 females for genotyping by Ion Torrent sequencing; Core B will perform sequencing.
All female G3 pups will be monitored every other day for the development of T1D over a period of 40
weeks. Experimental observations will consist of first detection of glucosuria confirmed by hyperglycemia. For
all mice ear tag numbers, birth dates, and phenotypic data will be uploaded to the Mutagenetix database, so that
Kaplan-Meier analysis can be performed weekly to take account of new developments in every pedigree. We
will perform similar phenotypic analyses of pedigrees carrying CRISPR/Cas9-targeted mutations generated in
Project 2, for the purposes of verification. Preliminary data confirm that modification of the NOD/NckH T1D
phenotype can be achieved, and causative mutations instantly mapped, fully supporting the discovery program
we propose. We will perform extended monitoring (through 40 weeks of age) to detect all phenotypes including
those of lesser magnitude, but we will gain time by identifying the strongest causative mutations early on. When
each G1 male has completed G2 breeding, epididymal sperm will be harvested for cryopreservation and public
distribution via the MMRRC; the mutations and their phenotypic effects will be made public on the Mutagenetix
website. At times, verification of causation depends on placing a knockout allele in trans with the original ENU-
induced allele. Therefore, as indicated, we will transfer cryopreserved sperm from Core C to Project 2, where
germline re-targeting will take place in the NOD/NckH strain. The close interaction between Core C and Core B
will include shipment of DNA at monthly intervals from Core C to Core B and uploading of phenotypic data on a
weekly basis. This will guarantee the identification of many novel modifier mutations to fuel the activities of
Project 1 and Project 2.